PHARMACOKINETIC/PHARMACODYNAMIC RELATIONSHIP FOR SCOPOLAMINE AFTER IV INFUSION

To investigate the pharmacokinetics and pharmacodynamics of intravenous administration of scopolamine. To assess dosage and possible gender effects on changes in Electorencephalography, heart rate, saliva flow, psycometric tests and sedation scales.